Partnership to Assess Viral and Immune Landscape Intersections with ONcology for People Living with HIV (PAVILION)

PROJECT SUMMARY – OVERALL
The partnership center, entitled Partnership to Assess Viral and Immune Landscape Intersections with Oncology
(PAVILION) for People Living with HIV Program will bring together experienced research sites and world-
renowned HIV, human papillomavirus (HPV), Epstein Barr Virus (EBV), and cancer researchers to offer a novel
contribution to the HIV-Associated Malignancies Research Center network. The PAVILION theme is research
of understudied, virus-associated tumors that disproportionately impact men and women living with HIV
in sub-Saharan Africa (SSA). SSA remains home to two thirds of people living with HIV (PLWH). HIV-related
immunosuppression results in an inability to control viruses and therefore a higher risk of virus-associated
cancer, even among PLWH on effective antiretroviral therapy. The increasing life-expectancy of PLWH
compounds this cancer risk as cancer is now a leading cause of mortality among PLWH in both high and low
resource countries. Furthermore, PLWH experience poorer cancer treatment outcomes. Despite this, few studies
of cancer etiology and cancer outcomes among PLWH in LMICs have been conducted, with little focus on HPV
cancers at extra-cervical anatomic sites and very few studies of a suspected viral etiology for conjunctival tumors.
PAVILION will therefore focus on the full range of cancers caused by HPV (anal, cervical, oropharyngeal, penile,
and vulvar cancers) and the potential role of EBV in conjunctival squamous cell carcinoma - cancers that are
disproportionality higher among PLWH, and which result in substantial morbidity and mortality.
The overall goal of PAVILION is to provide the data necessary to inform prevention and therapeutic strategies
to reduce the burden of cancers among PLWH in SSA. PAVILION includes partners in South Africa and
Zimbabwe, multiple institutions in the US, and the DKFZ in Germany. Notably, Zimbabwe and South Africa have
among the highest prevalence of HIV in Africa and have a rapidly increasing cancer burden that is largely
comprised of infection-associated cancers. As a partnership, we have long standing collaborations, outstanding
research leadership, mutual prioritization of the cancers to study, and institutional and consortium experience
that will facilitate translation of scientific findings to achieve our goal. Specific Aims supporting this goal are:
Aim 1: Establish a multi-national partnership with research infrastructure (Administrative & Coordinating,
Central Laboratory, and Data Management & Statistics Cores) to conduct collaborative, innovative, and
impactful research that advances prevention and treatment of infection-related cancers among PLWH in SSA
Aim 2: Understand the fraction of tumors attributable to specific oncogenic viruses (i.e., HPV, EBV), the
characterization of the immune microenvironment of tumors unique to the setting of HIV, and a more complete
understanding of clinical outcomes for PLWH and cancer in SSA (Projects 1 and 2)
Aim 3: Build capacity through active mentorship and training programs (Administrative & Coordinating and
Developmental Cores) for early stage and junior faculty at partnership institutions

Public health relevance
PROJECT NARRATIVE – OVERALL The Partnership to Assess Viral and Immune Landscape Intersections with Oncology for People Living with HIV Program (PAVILION) will bring together experienced research sites and world-renowned HIV, human papillomavirus, Epstein Barr Virus, and cancer researchers to offer a novel contribution to the HIV-Associated Malignancies Research Center network. The PAVILION theme is research of understudied, virus-associated tumors that disproportionately impact men and women living with HIV in sub-Saharan Africa with the overall goal of providing the data necessary to inform prevention and therapeutic strategies to reduce the burden of cancers among people living with HIV and cancer in this region. This partnership will directly address the urgent need to mitigate a rapidly rising cancer burden that is largely comprised of infection-associated cancers in two partnering low- and middle-income countries (South Africa and Zimbabwe) that have among the highest prevalence of HIV infection in Africa.